Engineering Core

Engineering Core
The goal of the Engineering Core is to enable our Team members to surmount their most challenging
technological and engineering obstacles. There are many needs for engineering solutions in our proposal --
from behavioral apparatus to optical and electrophysiological rigs, to software for data acquisition and
analyses. Even the most technologically sophisticated of the research groups in our Team require special
assistance with engineering problems in order to achieve our ambitious aims. In the Center for Brain Science
at Harvard there is an existing Engineering Core that consists of
(a) an integrated laboratory to design, prototype, iterate, and produce custom devices for neuroscience
experiments
and
(b) Dr. Brett Graham, an engineer-neuroscientist who solves the most challenging engineering problems in the
user laboratories and trains young scientists to do this themselves.
By adding a dedicated staff engineer, the Engineering Core is able to support the team-based neuroscience
research proposed here. The specific aims are to implement engineering solutions to problems faced by the
Projects and other Cores. The Engineering Core will (a) design and build apparatuses to image rapidly
swimming larval zebrafish; (b) build rigs to record neural activity in larval zebrafish brains and hearts via
calcium imaging; and (c) further automate the connectomics imaging pipeline.

Public health relevance
The research plan we propose aims at a comprehensive multi-level understanding of how the brain and the body interact to respond adaptively to a potentially harsh and unforgiving environment. Among the many internal factors that are under constant homeostatic regulation, we focus on the bi-directional dialogue between the brain and the heart, since the cardiovascular system and its role in regulating oxygen delivery is one of the most critical and universal control systems within the animal kingdom. A central aspect of our approach is the generation of a complete brain and body connectome of the larval zebrafish, a map which will be the first ever generated in a vertebrate, and which will be critical in both testing the validity of many extant models, and perhaps discovering new pathways within the interconnected neural circuits that serve the changing needs of the body during behavior.